Research Support Core B: Primary Cell, Biomimetic, and iPSC-derived Cell Models

Project Summary - Primary Cell, Biomimetics, and iPSC-derived Cellular Models Core B
Understanding the mechanism(s) by which cocaine, methamphetamine, cannabis, and opioids
amplify the damage of HIV latency is a central goal of the CWRU Center for Excellence on the
Impact of Substance Use on HIV. Our understanding of HIV latency and persistence has been
complicated by the small numbers of latently infected cells found in the circulation, the difficulty
of obtaining comprehensive sets of tissue samples from patients, the lack of known phenotypic
markers that can distinguish latently infected cells from uninfected ones, and limited information
about the behavior of tissue reservoirs in vivo. Core B will provide both ex vivo primary cell models
(Aim 1) and highly sensitive nucleic acid-based assays to measure the impact of substance use
on the HIV reservoir (Aim 2) in clinical samples. A key unresolved issue is how each individual
drug modulates the latent HIV reservoir in multiple cell types and tissues. The Primary Cell,
Biomimetic, and iPSC-derived Cell Models Core B team will provide and develop for Center
investigators innovative and highly informative cellular and biomimetic models for the three main
organ targets of drug use and HIV – the brain, gut, and the immune system. Organoids derived
from tissue explants and induced pluripotent stem cells (iPSC) will be used to mimic the tissue
microenvironment and extend the range of assays beyond what can be achieved using single cell
ex vivo models. The models offered by Core B will be used throughout the Center of Excellence
to evaluate the impact of drug use on HIV latency and will also be established ex vivo with samples
derived from persons with Substance Use Disorder and HIV on anti-retroviral therapy. These
models will each reflect the diversity of molecular mechanisms governing the response to drug
use and HIV latency in CD4 T cells from the periphery, mucosal T cells from the gut, and
microglial, neuronal, and microvascular endothelial cells from the CNS and will also provide
unique opportunities to contrast the effects of substance use in vivo with direct cell biological
analyses ex vivo. Importantly, the Core B team will continue to develop new assays and methods
to study the impact of substance use on the mechanisms of HIV persistence and latency. In
particular, this effort includes (a) developing single cell RNA induction assays, (b) modeling the
TFH compartment, and (c) advancing iPSC-derived cerebral organoids to study drug use and HIV
latency in the CNS. Thus, Core B, in collaboration with the molecular services in Core C, will
provide access to novel technologies for evaluating the cellular, proteomic, microbiological,
metabolomic, and transcriptomic changes associated with substance use and their impact on HIV
reservoirs in patient samples available in Core D and to primary cell cultures and tools to
manipulate cells that would not otherwise be available to Substance Use researchers at our
institutions and nationwide.

Public health relevance
Project Narrative – Primary Cell and iPSC-derived Cellular Models Core B Understanding the latent state of HIV and how it is impacted by substance use, specifically cocaine, methamphetamine, and opioids, is a central goal of the CWRU Center for Excellence on the Impact of Substance Use on HIV. Core B will provide primary cell ex vivo models and highly sensitive nucleic acid-based techniques to detect inducible viral RNA in cells recovered from patients. These assays will yield essential information about the control of latency in the brain, gut, and immune system. The Core will provide tools to manipulate and analyze primary cells that would not otherwise be available to Substance Use researchers at our institutions or nationwide.